Molecular pathogenesis of pulmonary arterial hypertension

PROJECT SUMMARY/ABSTRACT
Pulmonary Arterial Hypertension (PAH) is a rare disease characterized by the progressive remodeling of
pulmonary arteries (PAs). It is incurable and leads to death from right ventricular heart failure in 3 years if
untreated. Heterozygous mutations of the bone morphogenetic protein type 2 receptor gene (BMPR2) are the
leading genetic cause of both heritable and non-heritable PAH. Compared to patients without BMPR2
mutations, PAH patients with BMPR2 mutations develop a more severe form of PAH at least 10 years earlier.
Despite the progress in understanding the molecular and cellular processes mediating occlusive remodeling of
PAs as a result of BMPR2 mutations, a targeted therapy does not yet exist, and BMPR2 carrier patients remain
at high risk of requiring transplantation and succumbing to the disease. There is a dire need of novel therapies
for BMPR2 mutation patients.
Our studies demonstrated increased DNA damage in both idiopathic- and heritable-PAH patients,
suggesting genotoxic stress is a risk factor for PAH, but significant knowledge gaps persist, as follows: (i)
whether the loss of genome integrity is the cause or the consequence of PAH, (ii) the cell type in which DNA
damage occur, (iii) a potential link between BMPR2 mutations and DNA damage, and (iv) the molecular
mechanism of DNA damage in PAH. We found that BMPR2 and its downstream signaling pathway are
essential to protect genome integrity in pulmonary artery endothelial cells (PAECs), and they act by
maintaining a key component of the DNA repair pathway: Rad51. Inactivation of BMPR2 results in reduction of
Rad51, leading to accumulation of DNA damage in PAECs. Attenuation of Rad51 was measured in the
endothelium of both animal models of PAH and human patients. On the contrary, activation of the BMPR2
signaling pathway by BMP9 restores Rad51 and prevents the accumulation of DNA damage in PAECs. The
main hypothesis we will test is that PAECs undergoing genotoxic stress develop a pathological remodeling and
PAH. The objective of this application is to develop a strategy to restore the DNA repair system in PAECs and
prevent or inhibit the progression of vascular remodeling, as a novel therapy for PAH with a defective BMP
signal. The forthcoming results from this application will provide important insights into developing a novel
therapeutic strategy for PAH.

Public health relevance
PROJECT NARRATIVE Pulmonary arterial hypertension (PAH) is a progressive vascular disease with high morbidity and mortality. The etiology of PAH is poorly understood and currently there is no cure. This application aims to elucidate a role of DNA damage during the pathogenesis of PAH and to shed light on novel therapeutic strategies for PAH.